Improving risk allocation and developing novel therapies for children with T-ALL and T-LL

Project Summary/Abstract
The treatment for children and young adults with T-cell lymphoblastic leukemia (T-ALL) and T-cell lymphoblastic
lymphoma (T-LL) has harmonized over time as T-LL patients were shown to have superior outcomes with T-ALL
therapy. The recently completed Children’s Oncology Group (COG) phase 3 clinical trial AALL1231, however,
found that T-LL but not T-ALL patients had improved event-free survival (EFS) and overall survival (OS) when
randomized to the proteasome inhibitor bortezomib plus cytotoxic chemotherapy vs chemotherapy alone. In
addition, corticosteroids were intensified on AALL1231 to eliminate prophylactic cranial radiation in most children.
T-ALL patients benefited from the corticosteroid intensification and T-LL patients did not. This trial changed the
treatment paradigm for T-ALL and T-LL and it is critical we identify the mechanisms underlying the differential
response to therapy. For T-ALL patients, we performed comprehensive -omic analyses under R01CA193776
and an associated Gabriella Miller Kids First X01 award (X01HD100702). These studies included proteomic
profiling on over 250 children with T-ALL and whole genome, whole exome, and RNA sequencing (WGS, WES,
RNAseq) on over 1250 children with T-ALL. We also performed single cell genomic profiling (scRNASeq) on
bone marrow from 30 T-ALL cases to understand clonal architecture and microenvironment. We now have
access to tissues from over 250 children with T-LL which we will use to test our central hypothesis that specific
proteomic, transcriptomic, and genomic profiles can: (1) identify patients with T-ALL and T-LL that have a higher
risk of relapsing, (2) define patients that have a higher likelihood to benefit from novel therapies, and (3) delineate
intrinsic (tumor) and extrinsic (microenvironment) biologic differences that lead to the differential response to
therapy. We will leverage and expand our existing T-ALL data and generate new data in T-LL to test our
hypothesis with the following specific aims. We will perform bulk genomic, transcriptomic, and proteomic profiling
on T-LL tissues, as well as single cell profiling on T-LL bone marrow and T-ALL and T-LL CSF and compare the
tumor and microenvironment in T-ALL and T-LL to identify biologic differences between the two (Aim 1). We will
perform transcriptome and proteome profiling to define mechanisms of sensitivity and resistance to
corticosteroids (Aim 2) and proteasome inhibitors (Aim 3) in T-ALL and T-LL and target dysregulated proteins
driving resistance with small molecule inhibitors and CRISPR-Cas9 to overcome drug resistance.
Impact: We are uniquely positioned to perform highly innovative studies in samples collected from children and
young adults with T-ALL and T-LL treated on multi-center phase 3 trials. We will improve understanding of T-
ALL and T-LL biology and define intrinsic (cancer cell) and extrinsic (microenvironment) biologic factors that
distinguish the two. We will identify which T-ALL and T-LL patients should receive proteasome inhibitors and
intensified corticosteroids as standard therapy and identify novel targets for the next generation of clinical trials.

Public health relevance
Project Narrative Children and young adults with T-cell lymphoblastic leukemia (T-ALL) and T-cell lymphoblastic lymphoma (T- LL) are usually treated the same. We have new data from clinical trials showing that T-ALL and T-LL patients respond differently to glucocorticoids and proteasome inhibitors. We need to understand why they responded differently so we can develop better treatments and cure more patients.